GORDON CONFERENCE--NUCLEAR PROTEINS

DESCRIPTION (Adapted from Applicant's Abstract): This proposal is to fund the 12th meeting of the Gordon Conference, entitled "Nuclear Protein, Chromatin Structure and Gene Regulation". Since its inception in 1972, the "Chromatin"Conference has regularly convened every other year. Few other conferences of any kind cover the diversity of advances in the field of eukaryotic chromosome structure and function. This conference was held at Tilton School, Tilton, New Hampshire, from July 17-22, 1994.